Developing novel 3D printed grafts for nasal reconstruction

Abstract
Complex nasal reconstruction often requires significant donor cartilage to augment and
reconstruct large defects. The scarcity of septal cartilage compels surgeons to resort to
harvesting costochondral rib cartilage for nasal grafts. Cadaveric costochondral grafts or
synthetic materials (both permanent and resorbable) are occasionally used. Each approach
carries its own significant drawbacks, underscoring the unmet need among surgeons for a
solution that combines the ease of use and unlimited supply of synthetic grafts, with the
mechanical properties of native cartilage. Mobius Biotech has developed a novel 3D printed
polycaprolactone (PCL) nasal graft the Resorb3D Spreader Graft (RSG), using Resorb3D, its
innovative platform technology to produce resorbable implants for nasal and facial
reconstruction. The RSG is a standardized off the shelf graft designed with a bilevel pore
geometry, with smaller pores for tissue ingrowth and larger pores to accommodate cartilage
tissue biopsies and engineered to mimic the mechanical properties of costochondral cartilage.
By minimizing the need for cartilage harvesting surgeries, the RSG will significantly reduce the
overall risk, cost, and surgical time for complex nasal reconstruction, thus benefiting a broad
range of stakeholders including patients, surgeons, hospitals, and insurers.
The Specific Aims of this SBIR will evaluate and test the RSG prototypes in an in vivo
rabbit animal model, focusing on tissue integration, inflammation, and nasal reconstruction
efficacy as compared to PDS plates. The mechanical and material properties of both RSG and
PDS will also be compared to costochondral grafts to assess implant extrusion risks. Currently,
PDS plates are the only available resorbable implants used by surgeons to augment septal
cartilage during nasal reconstruction. Aim 1 will compare the material and mechanical properties
of RSG and PDS plates to nasal septal and rib costochondral cartilage. Aim 2 will compare in
vivo tissue integration, inflammatory response, and mechanical performance of the RSG vs
PDS plates implanted bilaterally in a rabbit rhinoplasty model. Outcomes will determine
mechanical properties and in vivo performance of RSG vs PDS plates during
resorption/degradation post implantation. Aim 3 will help Mobius Biotech engage with a
regulatory consultant to understand FDA requirements, start working on a Design History File
(DHF) and better prepare for the SBIR Phase II.

Public health relevance
Project Narrative This project proposes to assess the in vivo degradation and tissue response of a 3D printed polycaprolactone implant having a bilevel pore design designed to accommodate tissue biopsies and mimic mechanical behavior of costochondral cartilage. The first and second aims will compare the mechanical properties and the in vivo tissue integration, inflammatory response, and mechanical performance of the RSG vs PDS plates implanted bilaterally in a rabbit rhinoplasty model. The third aim will engage a regulatory affairs specialist to design the animal study required for FDA approval and start work on a Design History File (DHF) for the RSG.